Longitudinal Study of Mexican American Elderly Health

ABSTRACT
This application seeks funds to conduct one more in-person follow-up (wave 10) of the Hispanic EPESE
(Established Population for the Epidemiological Study of the Elderly) surviving subjects (AGED 90+) and their
caregivers, many of whom were interviewed in 2016 (Wave 9) and/or in 2010-11 (Wave 7). We propose the new
field work for 2019-20. The baseline was conducted during 1993-94 when a representative sample of 3,050
Mexican Americans aged >65 residing in Texas, New Mexico, Colorado, Arizona, and California were
interviewed. At Wave 5 (2004-05), a new cohort of 902 subjects aged >75 was added. The proposed contact will
be our tenth for the original subjects plus the third contact for most of the caregivers whom we interviewed in
2010-11 and 2016. At our last contact in 2016 we interviewed 480 subjects that were aged >88 plus 460
informants, most of whom were family caregivers. Our specific aims below are based on our key findings from
the previous nine waves, and the limited information on the health and health care needs of the “oldest old”
Mexican Americans. This is a long living population with a current life expectancy at birth of approximately 2.5
years higher than that of non-Hispanic Whites (Arias, 2014) despite their generally lower socioeconomic status
(Markides and Eschbach, 2005; 2011). We expect to re-interview at least 300 survivors aged >90. We also plan
to interview their caregivers (N=300) most of whom were interviewed in 2016 and some of them also interviewed
in 2010-11. The Hispanic EPESE has been a multipurpose study with contributions to numerous aspects of aging
in the Mexican American population. The proposed application will also have multiple aims mostly centered on
the health and health care needs of the “oldest old” Mexican Americans with special attention to their caregiving
needs and caregiving arrangements. Also of interest are factors that contribute to survival to such advanced
ages. Our primary aims are: Aim 1. Assess the dynamics of caregiving and living arrangements of very old
Mexican Americans over a nine-year period (2010-2011 to 2016 and to 2019-2020) by obtaining information
from both elderly subjects and their caregivers. Aim 2. Examine the association of changes in the subjects’
physical, cognitive, and mental health on the mental and physical well-being and quality of life of caregivers. Also
examined are factors influencing changes in caregiving arrangements, as well as changes in living arrangements
including institutionalization. Aim 3. Identify predictors of survival, change in disability, change in cognitive
function, and level of psychiatric disturbance in the oldest old subjects from Wave 7 (2010-11) to Wave 9 (2016)
and Wave 10 (2019-20). Aim 4. Conduct a more extensive assessment of cognitive function of the 300 oldest
old subjects and examine their association with caregiver arrangements, caregiver burden and quality of life of
their caregivers (N=300). Aim 5. Archive proposed Wave 10 data with NACDA (the National Archive of
Computerized Data in Aging). Waves 1 to 8 have been archived with NACDA and Wave 9 collected in 2016 will
be archived this year.

Public health relevance
PROJECT NARRATIVE The Hispanic EPESE is an on-going study of older Mexican Americans residing in the five Southwestern states: Texas, New Mexico, Colorado, Arizona, and California. Information obtained has relevance to health and social policy aimed at maintaining or improving the quality of lifer of older Mexican Americans.